HIV Vaccine Trials Network Laboratory Center - B-Cell and Molecular Assay Multi-year Supplement

Abstract
Accelerating B Cell and Antibody Molecular, Functional and Structural Analysis
in Sequential bnAb-inducing Env Immunogen Clinical Trials
Development of an effective HIV vaccine is essential for achieving long-term immunity to prevent new HIV
infections globally. A successful HIV vaccine regimen will likely need to induce potent broad neutralizing
antibodies (bnAbs) to contemporary circulating viral strains. New HIV Env immunogen designs, guided by
knowledge of bnAb interactions with envelope epitopes and their B cell clonal lineage development in natural
HIV infection, have entered first in human studies in the HVTN. These phase 1 “discovery” trials rely on more
efficient, near real-time molecular, functional, and structural analyses of B cell and antibody responses. To meet
this expectation, the HVTN Laboratory Center proposes to continue expansion and improvement of laboratory
and analytical capacity that can accelerate iterative evaluation of bnAb-inducing vaccine candidates. The
supplemental funds for the HVTN Laboratory make it possible to fully access evolving immunologic, molecular,
and structural technology, which deepens our laboratory analyses and increases throughput of data generation
and interpretation. To accomplish this, we will sustain the employment of additional dedicated trained staff and
equipment to increase laboratory throughput of B cell repertoire, antibody binding with epitope mapping,
neutralization, and antibody structural analyses. These funds will continue to enable efficient laboratory
operations and integration of the scientific partnerships between key investigators at Fred Hutch, Duke
University, and the Scripps Research Institute.

Public health relevance
Project Narrative Development of an effective preventive vaccine is essential to achieve long-term immunity against HIV infection. A successful HIV vaccine will likely need to induce potent broadly neutralizing antibodies to circulating viral strains. We seek to comprehensively and rapidly assess the evolution of neutralizing antibody responses induced by candidate Env immunogens to select the most promising vaccine regimens that might eventually induce broad neutralization of contemporary circulatory HIV-1 strains globally.